Adenosine Signaling in Bronchopulmonary Dysplasia

Bronchopulmonary dysplasia (BPD) remains a significant cause for morbidity and mortality in
premature neonates. BPD occurs in approximately 1/3 of infants less than 1000 grams and is associated with
worse developmental outcomes, increased re-hospitalization and long term complications of lung function.
The neonatology community remains without an effective therapy to prevent or treat BPD. There remains a
critical need to determine the key regulatory pathways in order to develop novel therapeutic options in the
prevention and treatment of BPD. Adenosine is a signaling molecule that regulates pulmonary processes
including inflammation and alveolar development, and there is significant evidence that adenosine could be a
critical regulatory pathway in BPD. However, its role in the pathophysiology of BPD remains unknown.
The overall hypothesis is that adenosine signaling in premature neonates disrupts normal alveolar
repair and contributes to the inflammation and disrupted alveolar development observed in BPD. Aim 1 will
utilize an animal model of BPD to determine adenosine's regulation of repair including pulmonary inflammation
and alveolar development. Aim 2 focuses on adenosine's signaling effect on alveolar type 2 cell populations
which play an important role in long term consequences of hyperoxia after birth. This project will provide
important insight into the role of adenosine signaling in the premature lung and will help-guide the pre-clinical
rationale for the long-term goal of developing novel therapeutic strategies targeting adenosine signaling for the
prevention and treatment of BPD.
Dr. Jonathan Davies has a prolific history of scientific research throughout his training. These projects
ranged from basic research, innovative and collaborative research projects, and clinically applicable research
projects. Dr. Davies' advancement through his research and clinical training have provided him the ability to
assemble a research environment that facilitates success. This includes the physical environment and an
outstanding mentorship environment with established and productive researchers with extensive histories of
mentoring young scientists to independence. The research and career development plans describe in this
proposal are a natural progression for Dr. Davies into a career of independent research with the primary goal
of significantly improving the outcomes of premature neonates by developing novel therapies to prevent and
treat BPD. Additionally, the career developmental plan included with this award will provide the coursework,
conferences and meetings that will complement his clinical work and mentoring by a team of interdisciplinary
scientists with relevant expertise. Dr. Davies' training environment is outstanding and includes institutional
support with dedicated space and protected time, and scientific support by mentors and collaborators with
expertise relevant to his research plans and career goals. This environment will assure success with the
proposed project and his advancement in his career towards independent research.

Public health relevance
Title: Adenosine Signaling In Bronchopulmonary Dysplasia Bronchopulmonary dysplasia (BPD) remains a significant cause for morbidity and mortality in premature neonates. There remains a critical need to determine the key regulatory pathways in order to develop novel therapeutic options in the prevention and treatment of BPD. My proposed work aims to evaluate the role of adenosine signaling in the repair processes in the pathophysiology of BPD including effects on pulmonary inflammation and alveolar development in the premature neonatal lung.